Climate Penalty: Climate-driven Increases in Ozone and PM2.5 Levels and Mortality

Project Summary
Climate change is the greatest public health challenge of the 21st century. While numerous pathways of the
health impact of climate change have been proposed, the “climate penalty” effect, i.e., a warming temperature
worsens ambient air quality and consequently influences human health, remains poorly understood, resulting in
an underestimated public health burden associated with global warming. Our previous epidemiological studies
have reported that higher summer mean temperatures and higher PM2.5 concentrations are each associated with
increased all-cause mortality in the Medicare population (aged ≥65) in the Southeastern US (SEUS)1, 2. Satellite
and ground-based observations suggest a strong dependence of air pollution on interannual variabilities of
summer mean temperature in SEUS3. These findings suggest that the indirect health effect of temperature via
the climate penalty on air quality can be potentially important in the SEUS region, in addition to the direct adverse
effects that we observed. However, clear epidemiological evidence of the air pollution serving as a mediator for
the health effects of temperature, and accurate estimate of this effect is still missing in current literature. Herein,
drawing on our preliminary results, we hypothesize that rising temperature can indirectly affect all-cause mortality
via worsening both PM2.5 and ozone levels in the SEUS. We propose a study that will leverage the Medicare
cohort from 2000-2016 (124 million person-years), the largest longitudinal cohort available for the SEUS and the
high-resolution temperature, PM2.5, and O3 data, to investigate all-cause mortality in response to the “climate
penalty” effect using a mediation statistical analysis. Specifically, in this project we will (1) update the present-
day temperature and ozone predictions at 1-km2 grids across the SEUS through 2016 by incorporating ensemble
averaging of machine learning models; (2) quantify the health effect of “climate penalty” on all-cause mortality
using a mediation analysis, and explore whether mitigating anthropogenic air pollution emissions might serve as
a pathway of climate change adaptation; (3) perform a risk assessment on the excess deaths related to the
climate penalty on air pollution for the mid- (2050) and late-21st century (2100), using climate model output,
chemical transport modeling, along with the top-down estimate of “climate penalty” from Aim 2. The proposed
research will improve understanding of the interplays between climate, air pollution, and human health based on
real-world big data, and provide epidemiological evidence of an important pathway that climate change adversely
affects human health, with immediate relevance to climate and environmental policymaking.

Public health relevance
Project Narrative This project aims to estimate the health effect of “climate penalty”, i.e., the rising temperature indirectly affects human health via worsening ambient air quality (primarily PM2.5 and ozone levels) using a mediation analysis based on satellite-retrieved exposures and Medicare all-cause mortality. We will test the hypotheses that 1) the indirect health effect of a warming climate by worsening air quality can be a major public health burden of future climate change, and 2) improving air quality by reducing anthropogenic emission can mitigate the health effect of climate penalty. We will also forecast the excess deaths in 2050 and 2100 related to the climate penalty on air pollution using climate model ensembles simulated for different emission scenarios.